Scientific Human Biomarker Exposure Monitoring Core (HEMC) for the Air pollution disrupts Inflammasome Regulation in HEart And Lung Total Health (AIRHEALTH) Study

ABSTRACT: HUMAN BIOMARKER EXPOSURE MONITORING CORE (HEMC)
The Scientific Human Biomarker Exposure Monitoring Core (HEMC) is a state-of-the-art Core Laboratory at
Stanford School of Medicine that builds on the extensive experience of the Stanford Human Immune Monitoring
Core Laboratory (HIMC). The HEMC will serve the aims of Projects 1, 2 and 3 by performing comprehensive,
standardized immune-based cell culture assays, and cardiovascular assays. The overarching goals of the HEMC
are to manage and process biomarker samples, define the multidimension biomarker profile of pollutant
exposure, and to provide state of the art assays for epigenic modifications relevant to pollutant exposure. The
results of the experiments performed by the HEMC will be central to the individual projects of this PPG by
providing needed samples to the individual projects and guiding the use of the most informative samples for
mechanistic and modeling studies. To this end, our three specific aims are: Aim 1. To centrally bank air pollution
cohort plasma, peripheral blood mononuclear cells (PBMCs), RNA, and DNA, and to provide those specimens
to the PPG Projects for both standardized and customized assays; Aim 2. To provide standardized targeted
proteomics and gene expression assays instrumental for characterizing pollution exposure signature (PES) that
will be complimentary to the specific projects of the PPG; and Aim 3. To provide a standardized, innovative
epigenetic assay to enhance mechanistic findings in all projects. The HEMC brings together an unparalleled set
of Stanford technologies for inflammasome monitoring and mechanistic work. We have given careful and
systematic thought to the selection of assays to be performed that will evaluate different aspects of pollutant
exposure. Many of technologies used in the HEMC have been largely developed and optimized at Stanford and
validated by institutions outside Stanford, increasing our confidence for their application to the PPG projects. In
collaboration with the DMAC, the HEMC will offer innovative tools and support for this proposed PPG to enable
analysis of molecular mechanisms and to find therapeutic targets for the prevention and treatment of pollution-
related cardiopulmonary risks, as proposed in Projects 1, 2, and 3.